High Throughput Clonal Analyses of Gliogenesis in Neocortical and Paleocortical areas of the Mouse Brain

Project Summary
The brain critically relies on balanced production of neurons and glia during embryonic and early postnatal development.
Recently developed clonal lineage analysis has revealed the behavior of neural stem cells (NSCs) giving rise to neurons in
the cerebral cortex with unprecedented single-cell resolution. However, the clonal principles underlying the formation of
glia by NSCs remains unclear and has yet to be systematically investigated using these new technologies. Gliogenesis is
critical for proper neuronal functions and when disrupted, it can result in various neurological diseases. Reconstructing
how glia are generated from individual NSCs and organized in the cortex during development is essential to understand
the structure-function relationships and how they can be modulated by clone-specific factors. We have established a
genetically-based single-cell lineage tracing technique utilizing MADM (Mosaic Analysis with Double Markers) mice to
label NSCs in the developing cortex and begin to address this knowledge gap. Using this method we have found two
distinct populations of glia that occupy different territories of the cortex and its related structure the hippocampal
formation. The goal of the proposed research is to reconstruct, quantify, and mathematically model the behavior of
individually labeled NSCs in vivo in neocortical and paleocortical areas. This effort requires the development of
optimized imaging and analytical tools to ensure reliable and repeatable interpretation of quantitative data. To this end we
are developing light sheet microscopy and AI-based automated quantification methods to facilitate unbiased and precise
imaging and quantification of clonal data in the brain. Successful completion of our study will result in a comprehensive
map of single NSCs and their glial progeny in various cortical regions. Our approach will also establish a platform for
detailed quantitative and computational analysis of gliogenesis, glial diversity, and their potential for repair and
regenerative approaches in the cortex in the context of various neurological disorders and brain injury.
Potential for Broader Impact
Our approaches to understand how important constituents of the brain, the glial cells, develop have wide implications.
Disruption of glial development is the root of a range of pathological conditions in the brain. Therefore, understanding the
basic principles and cellular mechanisms that control gliogenesis is critical to appreciate not only how healthy
development may be controlled by systematic production of glial cells, but also how abnormalities in gliogenesis may
lead to devastating neurodevelopmental disorders and brain tumors.

Public health relevance
Public Health Relevance Statement This research proposal explores fundamental and basic mechanisms involved in gliogenesis, which is the production of important cell types in the brain that are critical for healthy brain functions. We will use new genetic labeling strategies to track the behavior of individual neural stem cells that give rise to glia in the developing cerebral cortex, and employ cutting-edge discovery and analytical methods to better understand the biological behaviors of these cells and their underlying principles. These studies will allow us to systematically map the origins of specific glial cells in the brain, and how defective gliogenesis effects physiological and behavioral aspects of forebrain function. Understanding these functions are fundamental for understanding glial responses to brain injury, degeneration, and disease, from multiple sclerosis and Alzheimer’s disease, to glioma, spinal cord injury, and stroke. Also, the technological pipelines developed in this project may become relevant to projects outside neurobiology where in vivo and/or automated quantification methodologies are applied.